Control of C. elegans Lineage by Heterochronic Genes

Project Summary/Abstract:
We have identified genes that act in the maturation or presentation of siRNAs that mediate antiviral defense
in C. elegans. We propose to discern how the siRNAs and other small RNAs may be edited analogous to
the ancient editing of wobble base pairs in the anticodon loop of many tRNAs, to allow this system to
anticipate infection with viruses related to virus infections recorded in the genome. Our saturation genetic
analysis of these antiviral pathways has revealed new possibilities for how the genomic record of past viral
infections via RNA editing and DNA recombination between repetitive elements can anticipate future viral
variation. This is equivalent to wobble base pairing between tRNA and codons, which is mediated by very
ancient RNA modification pathways. Thus the modern RNA world, which is heavily populated by parasitic
RNA viruses such as Covid-19, may depend on ancient RNA editing. Our hypothesis that synMuv genes
mediate gene amplification in the intestine and other tissues to produce substrates for unequal crossing over
is very unorthodox, but intersects nicely with the translocations so common in tumor biology. It could be
transformative for cancer biology.

Public health relevance
Project Narrative: RNA interference in the animal C. elegans is highly focused on antiviral defense, with particular Argonaute proteins from its expanded set of small RNA armaments and RNA dependent RNA polymerase proteins highly specialized for silencing of integrated viruses and new invading viruses. The new genes we have discovered and our lists of new candidate genes identify the key elements in the choreography of small RNAs in C. elegans. Because these genes are nearly all conserved across phylogeny, the rules we work out may apply to humans, with importance for human health. These genes are likely to be key factors in the function of small RNAs, and our work may enable more potent RNAi-based drugs.